INFLAMMATORY SIGNALING IN EPILEPTOGENESIS

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. The purpose of the project is to study the role of inflammatory signaling through PAF receptor activation as a basic mechanism of epileptogenesis. Specific Aim 1: To test the prediction that PAF accumulation promotes seizures and epileptic oscillations during kindling epileptogenesis. Specific Aim 2: To test the prediction that PAF promotes early inflammatory signaling that in turn participates in epileptogenesis. Specific Aim 3: To test the hypothesis that PAF accumulation induces interneuron damage. Specific Aim 4: To test that NPD1 will potentiate LAU-0901 neuroprotection after SE.